Investigating the plasticity of the follicular melanocyte stem cell system

Summary:
This grant aims to understand the plasticity of melanocyte stem cells (McSCs) and mature melanocytes (Mcs)
in adult hair follicles (HF). Our recent study revealed that all McSCs in early anagen undergo partial differentiation
and then make the decision to revert to a stem cell (SC) phenotype or go on to full differentiation. This newly
described mechanism challenges the previous belief that once the differentiation program is initiated in SCs, it
is not reversed in normal homeostasis. Many questions still remain unexplored in this new model, including:
What are the steps driving McSC partial differentiation and then either reversion to a SC state or full melanocyte
maturation? When does McSC plasticity end? i.e. can fully mature Mcs also undergo dedifferentiation? How
does this newly observed plasticity translate to human melanocytes? Addressing these questions will provide an
essential platform to advance this new SC paradigm. Further, understanding McSCs in particular is relevant
because melanocytes (Mcs) are critical for hair and skin pigmentation, and when dysregulated, they can result
in gray hair, skin depigmentation and melanoma.
In Aim 1, we will use innovative techniques and tools for live imaging to fully delineate the fate decision process
of McSCs. We will track the movement of individual McSCs from the onset of hair growth until their fate is
determined using a live imaging system. The regulatory mechanisms governing the ultimate fate of McSCs
remain largely unexplored. This is crucial, particularly in light of the understanding that the ultimate fate of SCs
involves dedifferentiation from a partially differentiated state within the McSC system. Our live imaging will help
us understand how McSCs interact with their environment during early hair growth and when they undergo final
fate decisions.
In Aim 2, we have found that all McSCs undergo partial differentiation in the onset of the hair follicle growth
phase, but they do not go on to full differentiation despite the fact that essential differentiation pathways have
been initiated. In examining McSC scRNAseq datasets for regulons, Foxd3, a TF known to repress melanocyte
embryonic development, came up in the 1st position. We will use Foxd3 KO and over-expression models to see
how its perturbation affects McSC differentiation. We predict that loss-of-function will induce full differentiation in
early anagen McSCs, and gain-of-function will promote a more undifferentiated state of McSCs.
In Aim 3, we will ask at what stage McSCs are no longer capable of complete dedifferentiation to a SC state.
Our preliminary results suggest that mature Mcs retain the potential to undergo full reversion to a SC state in ex
vivo assays. We will examine this potential in great detail, and both mouse and human Mcs will be investigated
for this potential.

Public health relevance
Narrative We showed that partially differentiated McSCs, previously believed to be destined only for differentiation, can revert to a true stem cell state. Here, we will examine the earliest and latest stages of McSC differentiation to understand how this plasticity is engendered and to what extent it extends. This work has important implications for melanocyte biology with possible repercussions for stem cell biology and regenerative medicine.